Baltimore CASCADE Study Site (BaCSS Project)

Baltimore CASCADE Study Site (BaCSS Project)
Project summary
Women living with HIV (WLWH) have a higher risk of cervical cancer because of incomplete immune
reconstitution and high prevalence of risk factors for cervical cancer. The risk is greater among African American
(AA) WLWH in economically and socially disadvantaged areas such as West Baltimore because of intersection
with race, gender, social determinants of health (SDOH), and HIV co-morbidities including substance abuse.
Despite the widespread availability of population-based cervical cancer screening in the US, AA-WLWH living in
disadvantaged areas have lower rates of screening uptake. Strategic evaluations of recently developed and
emerging methods and technologies for cervical cancer prevention in intended use settings are urgently needed
to address the cervical cancer prevention needs of this population.
In the BaCSS project, we engage the clinical and population science resources of the University of
Maryland School of Medicine (UMSOM) to establish a clinical study site for the CASCADE network. The site will
enroll AA-WLWH into implementation science studies and clinical trials of evidence-based interventions for the
prevention and early diagnosis of cervical cancer. The project provides operational leadership and pluripotent
infrastructure for these studies in the CASCADE network and supports the development of concepts and
protocols for pragmatic clinical trials of the effectiveness of clinically proven interventions to overcome barriers
and reduce failures in cervical cancer prevention in WLWH.

Public health relevance
Baltimore CASCADE Study Site (BaCSS Project) Project Narrative African American Women living with HIV in disadvantaged regions of the US have an increased risk of cervical cancer and require focused prevention interventions using novel and emerging technologies. In the BaCSS Project, we engage the population science and clinical trials expertise and resources of the University of Maryland School of Medicine (UMSOM) to establish a clinical study site for the CASCADE network. The project provides operational leadership and pluripotent infrastructure in support of the implementation science studies and pragmatic clinical trials of evidence-based interventions for the prevention and early diagnosis of cervical cancer and supports the development of concepts and protocols to overcome barriers and reduce failures in cervical cancer prevention in WLWH.